Effects of High Potency Cannabis Products on Mental Health and Psychosocial Functioning

The rapidly changing landscape of cannabis policy in the United States is well known, but often overlooked is
that legalization has made high-potency products more available. State-regulated cannabis markets offer
access to cannabis products, such as concentrates with THC potencies (70-90%) that far exceed cannabis that
has been sold on the black market over the last 20 years (4-12% THC potency). State reporting suggests that
concentrates are commonly used and quickly rising in popularity, with increases in 2014-2019 sales (409%) far
outpacing that of flower (80% increase) and edibles (234% increase). Recent data indicate that concentrate
users exhibit higher plasma THC levels than flower users and a large body of research has demonstrated
dose-response relationships between increasing cannabis consumption and poor mental health outcomes.
Given the increasing prevalence of concentrate use, it is imperative to clearly understand how these
increasingly popular, high-potency cannabis products affect mental health and psychosocial
functioning. This project leverages an ongoing, longitudinal twin study, with participants assessed
approximately every 5 years since adolescence. Thus, this project is a unique opportunity to rigorously test
critical hypotheses about how high-potency concentrates affect psychopathology and psychosocial functioning.
The Aims of this research are:
Aim 1: Examine how the use of different cannabis products relates to cannabinoid exposure (e.g.,
THC). We will test whether the use of high-potency cannabis concentrates, compared to flower products, is
associated with elevated cannabinoid exposure. We hypothesize that associations will not be explained by
familial confounds (via co-twin comparisons) and individual differences (via repeated assessments).
Alternatively, it is possible that concentrate users titrate to reach the same effect as flower users.
Aim 2: Examine how the use of different cannabis products relates to mental health and psychosocial
functioning. It is plausible that individuals vary in their propensity to use high-potency concentrates. Thus, we
will examine how use of high-potency concentrates relate to mental health while accounting for familial and
individual confounds, like genetics and prior substance use. We hypothesize that twins who uses more high-
potency concentrates will tend to have greater levels of depression, anxiety, and impulsivity and psychosocial
dysfunction compared to their co-twins who use flower or who use high-potency concentrates less frequently.
Aim 3: Test whether different levels of cannabinoid exposure are associated with mental health and
psychosocial outcomes. We will test how different levels of cannabinoid exposure (i.e., THC-COOH
concentrations in whole blood) associate with depression, anxiety, and impulsivity as well as psychosocial
functioning. That is, we will directly test the hypothesis that cannabinoid exposure is associated with mental
health and psychosocial functioning. We hypothesize that higher levels of cannabinoid exposure will be
associated with worse symptoms of mental health and psychosocial functioning.

Public health relevance
As more states have legalized cannabis, high-potency products such as concentrates have become more popular. However, very little is known about how the use of these products affects mental health or psychosocial functioning. Given the increasing prevalence of concentrate use, it is imperative to clearly understand how these increasingly popular, high-potency cannabis products affect mental health outcomes. This project will examine how concentrate use affects mental and psychosocial functioning by examining concentrate users over time, and also, by utilizing a co-twin control design, compare twins who use concentrates with their co-twin.